Minipig Model Validation for Hearing Research and Drug and Device Development

Project Summary
The field of drug delivery to the inner ear is facing a disaster. Otonomy, the most prominent company that led
the field for over 10 years, declared bankruptcy following clinical trial failures of multiple therapeutics.
Frequency Therapeutics, a second powerhouse, shut down all ear research after clinical trial failures of their
FX322 hearing restoration therapy. In the light of these failures, it has become appreciated that drug delivery
to the inner ear faces serious technical challenges. One of the primary tenets in pharmacotherapy is that the
applied drug must reach the target tissue to exert therapeutic effects. Many small molecules, which enter the
ear easily following local applications, readily leak from perilymph and do not distribute well along the length of
the cochlea. The limited distribution has been well characterized in guinea pigs. Computer simulations further
suggest that restricted drug distribution becomes a proportionately greater problem for the longer, human
cochlea. However, computer simulations alone carry little credence without supporting experimental
data. The failure of drugs to reach the intended target tissues needs to be clearly demonstrated by credible
measurements. We believe that the recent therapy failures could have been avoided if a well-studied
large animal model of the inner ear had been available. For the small molecules used in several
formulations (dexamethasone in Otonomy’s Otividex; gacyclidine in Otonomy’s OTO-313; Valproate in
Frequency Therapeutic’s FX322) confirmation of the inability to deliver drug to mid and apical regions of the
cochlea in a large animal model would have driven searches for alternative therapeutics with more suitable
pharmacokinetic properties. Today, we still have many biotech companies (some of which work with Turner
Scientific) developing therapeutics for the ear without a large animal model to evaluate the PK properties of
their formulations. Drugs that may not distribute along larger cochleas are still being pursued. It is imperative
to know when a therapeutic for hearing fails to reach the mid and apical regions of the cochlea. Without
supporting or opposing measurements, valuable research resources from both private investments and
federal grants will be squandered pursuing the development of “no hope” drugs towards failed clinical trials.
Turner Scientific will provide the hearing research community with the minipig as a large animal model for
drug pharmacokinetics and for implantable device development of the inner ear. But to accomplish this it
needs support collecting the baseline data which are required to establish the model in the field. Standard
measures for assessing drug efficacy and safety, including pharmacokinetic measurements, ABRs, DPOAEs,
and hair cell quantification will be validated in normal and noise-damaged mini pigs, furthering their utility in
preclinical studies. In the long-term, this investment will save years of time and resources, avoiding wasteful
research spending and perhaps preventing additional bankruptcies of those companies remaining in the
hearing therapy field.

Public health relevance
Project Narrative The minipig has an inner ear of comparable size and shape to the human making it an ideal model for translating experimental drug therapies and implantable devices to the human. We will characterize the pharmacokinetics of the minipig ear, collect objective measures of hearing, and generate noise damage models for the evaluation of protective drug therapies in minipigs. Establishing the minipig as the premier large-animal model for hearing research will save countless thousands of research dollars which would otherwise be spent on drugs that cannot be delivered effectively to target tissues in the mid and apical regions of the cochlea.